Deciphering the complex pharmacology of kappa opioid receptor: Towards the understanding of a third signaling pathway and its essential role in antipruritic effect

SUMMARY
Understanding the mechanisms underlying GPCR signaling is crucial in order to fully comprehend their role in
physiology and pathophysiology. In addition to canonical second messengers (cAMP, cGMP and IP3) and β-
arrestin signaling, small GTPase proteins, such as Rho GTPases are largely involved in GPCR-mediated signal
transduction. Guanine nucleotide exchange factors (GEFs) convert Rho GTPases from an inactive (GDP-bound)
state to an active state (GTP-bound). Rho-GEFs can be activated by Gq, G12/13 and Gs proteins. However,
currently there is no evidence that Gi/0-WT can directly activate RhoGEFs. PDZ domains are structural protein
domains that recognize simple linear amino acid motifs often at the protein C-terminal (C-motif). RhoA, activated
by PDZ-RhoGEFs, has important signaling roles, by activating phospholipase D (PLD) and transcription factors.
Kappa opioid receptor (KOR), an abundantly expressed GPCR that mainly couples to Gi/o, has a KPV C-motif
(last three amino acids) that binds PDZ class III proteins, including PDZ-RhoGEF. Our central hypothesis is that
KOR activation, in addition to engaging cAMP inhibition and β-arrestin pathways, initiates an additional signaling
mechanism downstream to PDZ-RhoGEF leading to activation of RhoA and subsequent activation of PLD.
Activation of PLD generates two distinct second messengers, phosphatidic acid, which activates the mTOR
pathway, and choline, which activates Sigma1 receptors. In addition to in vitro studies, this pathway that plays
an essential role in KOR signaling will be studied in vivo on antipruritic effects of KOR agonists. Antipruritic
effects of KOR agonists are well established and as of today, there is one FDA-approved KOR agonist
(difelikefalin) for the treatment of chronic itch of chronic kidney diseases. We will use a multidisciplinary approach,
combining state-of-the-art molecular and pharmacological approaches for a comprehensive investigation of the
signaling pathways elicited by activation of C-motifs of KOR. Receptor and PDZ-RhoGEF mutations,
measurements of second messenger levels (cAMP, choline and phosphatidic acid) as well as live imaging of
PLD activation will be used. Acute itch model of scratching will be used for in vivo studies. We provide solid
preliminary results supporting the feasibility of the project and the ability of our team to complete the work
proposed. The project has two aims: Aim 1. Investigate the role of PDZ-binding domain in KOR-induced
signaling; experiments are designed to characterize intracellular cascades activated by KOR-motifs (KOR-PDZ
binding domain). Aim 2. Investigate the role of PDZ-RhoGEF/RhoA pathway in antipruritic effects of KOR
agonists. RoA and sigma 1 receptor antagonists will be tested on scratch inhibiting effects of three different KOR
agonists (U50,488 as prototype, nalbuphine, and difelikefalin as peripherally restricted). The successful
completion of this project will increase the current knowledge of GPCR signaling and will serve as a basis for
further development of ligands selectively targeting this pathway and drug development in the itch field.

Public health relevance
NARRATIVE KOR is an opioid receptor that signals through canonical second messenger pathways (cAMP inhibition) as well as -arrestin. The goal of this proposal is to examine a new major pathway activated by KOR and to prove its essential role in KOR-induced anti-pruritic effect. The results of the project will increase the current knowledge of opioid signaling and role in prutitus.